Investigating Behavioral Mechanisms and Efficacy of a Provider-Directed Intervention for HPV Vaccine Promotion in Real-World Dental Settings

Project Summary
Human papillomavirus (HPV) is the leading cause of oropharyngeal cancers in the US. Despite the safety and
effectiveness of the HPV vaccine (HPV-V), coverage is far below that for other routine adolescent vaccines
and the Healthy People 2030 goal of 80%. HPV-V promotion at dental visits is seen as a prime opportunity to
prevent oropharyngeal and other cancers, yet many dental providers are not comfortable doing so due to lack
of knowledge and self-efficacy, and fear of harming the patient-provider relationship. Using the NIH Stage
Model of Behavioral Intervention Development as our guide, we propose to develop a theory-based
intervention to address dental provider barriers to HPV-V promotion, elucidate the intervention's behavioral
mechanisms, and test the real-world efficacy of the intervention in catalyzing provider HPV-V promotion. The
intervention will consist of 1) provider training about HPV/HPV-V; 2) tailored scripts to aid providers in
responding to patient/parent/guardian concerns about HPV-V. During the UG3 phase, we will randomize 21
HealthPartners Dental Group clinics to intervention vs. usual care (UC; n=~131 providers). UG3 aims are to:
develop survey measures and pilot-test provider HPV-V promotion training (Aim 1) and tailored scripts (Aim 2);
develop measures and methods for monitoring provider fidelity to the training and intervention activities (Aim
3); and draft compliance/study documents and obtain IRB/NIDCR approvals (Aim 4). During the UH3 phase,
we will conduct a cluster (clinic)-randomized clinical trial (intervention vs. UC) to test the real-world efficacy of
the intervention to increase HPV-V promotion activity (Aim 5). We will assess whether the intervention
impacted the three intended behavioral mechanism targets: increased knowledge of HPV/HPV-V; increased
self-efficacy for HPV-V promotion; and reduced fear of HPV-V promotion negatively affecting the patient-
provider relationship (Aim 6). For each target, we will also assess whether the intervention's effects followed
the full mechanistic pathway to the endpoint behavior, HPV-V promotion (Aim 7). Beyond our aims, we will
conduct exploratory work examining two additional candidate behavioral mechanisms: adequacy of material
resources to support dental providers in promoting HPV-V, and providers' perception that HPV-V promotion
comports with their professional identity. We will also conduct an exploratory analysis of the intervention's
efficacy in increasing HPV-V uptake (30-day post-visit patient vaccination rates). Our long-term goal is to
reduce HPV and oropharyngeal cancer prevalence through HPV-V promotion by dental providers. Significant
impact of the project includes: 1) developing the first theory-based behavioral intervention for HPV-V promotion
aimed at dental providers; 2) delivering the first evidence of real-world efficacy of such an intervention; 3)
illuminating behavioral mechanisms purported to underlie provider behavior change; 4) producing fundamental
knowledge to guide future HPV-V promotion intervention development; and 5) advancing the science of
behavior change by revealing behavioral principles underlying provider behavior change.

Public health relevance
Project Narrative Training dental providers to effectively promote the human papillomavirus vaccine (HPV-V) with their patients could prevent future HPV-related cancer of the mouth and throat in those who become vaccinated. This study will develop HPV-V promotion training and tailored scripts to support dental providers in promoting HPV-V. By testing this intervention in a real-world dental setting, this project has the potential to help increase HPV vaccination rates, reduce HPV-related cancers, and serve as a model for other organizations providing dental care.